Investigating NOP agonists as a novel treatment for chronic pain-associated sleep disruptions

PROJECT SUMMARY
Chronic pain is a debilitating disorder that effects 50.2 million people and is characterized by persistent pain
lasting three months or longer and negatively impacts mood, cognition, sleep, health, and quality of life. Sleep
disturbances are reported by 50-80% of patients with chronic pain that are not adequately targeted by
traditional analgesics. Given the importance of sleep in regulating general brain health and contributing to daily
function, developing novel analgesics that improve sleep disruptions represent a critical unmet need. Using
electroencephalography (EEG) in rats, we will 1) examine the duration and severity of sleep-disruptions in a
rodent model of sub-chronic neuropathic pain (partial sciatic nerve ligation; PSNL); 2) examine how current
analgesics oxycodone and gabapentin influence sleep and pain sensitivity in this model; and 3) investigate the
effects of Nociceptin/Orphanin Opioid (NOP) receptor agonists on sleep and pain. Similar to MOR agonists,
NOP agonists demonstrate analgesic activity, yet in contrast with MOR agonists, demonstrate low abuse
liability and improve sleep. I expect that PSNL will produce extensive disruptions in sleep duration and quality,
lasting 2-3 weeks. I hypothesize that oxycodone will significantly decrease sleep duration and quality in PSNL
rats, and that gabapentin will not impact sleep, both within analgesic dose ranges. Lastly, I hypothesize that
NOP agonists will reduce pain sensitivity and increase sleep duration and quality in PSNL rats. Collectively,
these studies will reiterate the importance of sleep disruptions associated with pain states, highlight unmet
need for novel treatments specifically targeting sleep disruptions, and test the viability of NOP agonists for the
treatment of chronic pain.

Public health relevance
PROJECT NARRATIVE Of the 50.2 million people affected by chronic pain, 50-80% report sleep disturbances that impact quality of life and daily function that are largely not improved by current pain medications. Present studies will use wireless electroencephalography (EEG) recordings in rats to rigorously examine sleep disruptions following partial sciatic nerve ligation (PSNL), a sub-chronic model of neuropathic pain, as well as effects of current pain medications, oxycodone and gabapentin, and a novel Nociceptin/Orphanin (NOP) receptor agonist. I hypothesize that all three treatments will produce analgesic effects, yet oxycodone will disrupt sleep further, gabapentin won’t impact sleep, and the NOP agonist will improve sleep, suggesting a novel treatment strategy for a currently undertreated symptom associated with chronic pain.